Cuproproteins for Redox Biology

All aerobic organisms continuously generate reactive oxygen species (ROS) such as superoxide anion and
H2O2 as natural products of metabolism. ROS are potentially damaging to biomolecules, but can also be
exploited by cells as weapons for attacking pathogens and as molecules for signaling. To balance the
beneficial and potentially harmful effects of ROS, aerobic organisms are armed with a suite of anti-oxidant
enzymes, and in eukaryotes, the only enzyme for superoxide is the superoxide dismutase (SOD). SODs use a
metal co-factor such as Cu to catalyze at extraordinary rates, the disproportination of superoxide to O2 and
H2O2. Until recently, the bimetallic Cu/Zn SOD was believed to be the only Cu SOD for eukaryotes, but in
2014, our lab discovered a new class of SODs that cannot bind Zn and lack sequences to cover the active site,
hence, a Cu-only SOD with a highly unusual solvent exposed Cu co-factor. Cu-only SODs are wide-spread
throughout the fungal kingdom as the sole extracellular SOD for fungi. In animals, the Cu-only SOD gene
underwent twice duplication, resulting in 4x tandem repeats of Cu-only SODs on a single polypeptide we call
CSRP (Cu-only SOD repeat protein). What sets the Cu-only SOD family apart from other SODs is their
restricted localization and unusual open active site. All Cu-only SODs and CSRP molecules are predicted to
be extracellular and remarkably, we find that Cu-only SODs do not acquire their Cu-cofactor from intracellular
metal pools, unlike other eukaryotic secreted cuproproteins. Instead, Cu-only SODs are activated outside the
cell by extracellular Cu. We hypothesize this new family of cuproproteins evolved to function exclusively
outside the cell in extracellular redox biology. Here we combine biophysical, structural biology, and cell biology
approaches to examine how the Cu site of Cu-only SODs is fine-tuned to capture Cu and not other metals
outside the cell, and how the enzyme functions with extracellular superoxide. In eukaryotes, the primary source
of extracellular superoxide is the NADPH oxidase (NOX), typically activated by Rho GTPases to produce ROS
for signaling. Recently, we uncovered a surprising NOX - Cu-only SOD partnership in a unicellular fungal
pathogen that represents a remarkably simple and unique form of Rho GTPase control of ROS. We will
elucidate the mechanism underlying this redumentary system for ROS signaling and define how pathogenic
yeasts can use Cu-only SODs and ROS to signal polarized growth. CSRP may likewise function in pathways
involving NOX and ROS signaling. Using a vertebrate model, we find CSRP most abundantly expressed in
tissues with a high capacity for regeneration by signaling through ROS. Our goals are to uncover the
biochemical activities of CSRP and elucidate its function in possible relationship to NOX in tissues with high
regenerative capacity. It is remarkable that nature has designed two distinct variations of Cu-containing SODs:
the Cu/Zn versus the Cu-only. Our studies promise to uncover how the Cu-only SODs are specialized to
operate outside the cell in redox and/or metallobiology.

Public health relevance
Project narrative In this proposal, we shall explore a new unique family of copper containing anti-oxidant proteins, including the superoxide dismutase enzymes needed for pathogenesis of Candida albicans, the most prevalent of human fungal pathogens.